Phage-based assay to measure daptomycin concentration in biological fluids

? DESCRIPTION (provided by applicant): Severe Gram positive infections are difficult to treat and associated with high mortality in hospital settings. Daptomycin is a broad spectrum antibiotic that has been successfully used to treat persisting Gram positive infections, including skin and soft tissue infections, right-sided endocarditis, and bacteremia. Daptomycin is also highly effective against drug-resistant strains such as methicillin-resistant S. aureus (MRSA) and vancomycin-resistant enterococci (VRE). Current daptomycin dosing guidelines are derived from limited studies in healthy individuals, where pharmacokinetics is highly predictable. Unfortunately, daptomycin pharmacokinetics are highly variable in the critically ill patients that typically receive the drug. This leads to sub-therapeutic dosing, increased rates of treatment failure, and recently, the emergence of daptomycin- resistant strains. Therapeutic monitoring of daptomycin concentrations would thus enable clinicians to adjust doses in order to maintain an effective circulating concentration, ultimately improving outcomes and preventing adverse effects. Unfortunately, there is no FDA-approved test to measure daptomycin concentrations in a clinical setting. Multiple clinical studies have concluded that current daptomycin dosing guidelines for critically ill and septic patients need to be reevaluated and adjusted, and regular measurement of daptomycin levels in these patients are needed to ensure effective treatment. To address this critical need, Affinergy has begun development of an assay to measure circulating daptomycin concentrations. We have identified a series of phage that bind with high affinity and specificity to daptomycin, and we are developing an ELISA-type assay using phage as a highly sensitive detection reagent. At the conclusion of Phase 1, we expect to have a technology that can be scaled up in Phase 2 for use by clinicians and researchers to measure daptomycin concentrations in biological fluids.

Public health relevance
PUBLIC HEALTH RELEVANCE: Daptomycin is successfully used to treat severe Gram positive infections, including methicillin resistant S. aureus (MRSA) and vancomycin resistant enterococci (VRE). Current daptomycin dosing guidelines are derived from healthy patients. However, daptomycin pharmacokinetics is highly variable in critically ill patients, and there are no FDA-approved assays that can be used to therapeutically monitor daptomycin concentrations in the clinic. In this application, we propose to develop a novel phage-based assay to facilitate measurement of daptomycin concentration in biological fluids.